Next generation implicit solvation for atomistic modeling

Project Summary. This proposal responds to PAR-19-253 “Focused Technology Research and
Development”. Our main goal is to develop a novel class of implicit solvation models, as accurate, and even
more accurate, than standard explicit solvent models, but much faster. The high accuracy, fast implicit
solvation models will be combined with several innovative strategies to deliver new computational protocols to
improve accuracy and speed of binding free energies prediction, directly relevant to drug design. We will
develop a computational tool for fast screening of existing and potential multiple simultaneous mutations in the
SARS-CoV-2 coronavirus genome for high affinity to human cells, which translates into high infectivity.
Progress in modern bio-molecular sciences, from structural biology to structure-based drug design, is
greatly accelerated by atomic-level modeling and simulations that bridge the gap between theory and
experiment. The so-called implicit solvation models can provide critical advantages in speed and versatility
through representing the effects of solvent – often the most computationally expensive part of such simulations
– in a particularly efficient manner. The resulting speed-up of modeling efforts is critical in many areas such as
protein folding or protein-ligand docking; however, the accuracy of the current fast models does not reach the
standard of the more traditional, but computationally very demanding explicit solvent approach. As a result,
prediction reliability of the practical, fast implicit solvation models remains low. In general, high accuracy is a
prerequisite for quantitative in-silico drug design. Here, the accuracy limitation of the current implicit solvation
framework will be addressed in a novel, systematic way; advantages of the new implicit solvation models will
be demonstrated in the context of improving the accuracy of protein-ligand binding free energy calculations.
We will use a novel approach to systematically add most of the missing explicit solvation effects to the
very basic, but computationally efficient implicit solvation framework of the Poisson and generalized Born (GB)
models, with little computational overhead. The GB model is particularly well suited for molecular dynamics
simulations. We have set high accuracy standards for the new theory: one kT (thermal noise) deviation from
experiment for small molecules hydration, which is better than what most widely used explicit water models,
such as TIP3P, can currently deliver. Based on preliminary results, this goal is within reach. The high accuracy
combined with the expected computational efficiency will usher in the next generation of implicit solvation
models that can make a profound difference in bio-medically relevant atomistic calculations.
Example of an immediate impact: Close to, or better than, “industry standard” accuracy in protein-
ligand binding calculations, but at a significantly reduced computational expense. Example of a long term
impact: Fast, versatile computational tools to analyze binding of viruses to host cells will increase our
preparedness for future pandemics.

Public health relevance
Project Narrative. Molecular modeling and simulations are indispensable tools in biomedical science and the drug discovery process. The proposed research will significantly enhance the capabilities of these tools and the likelihood of important discoveries by making the tools more accurate and efficient.